Clinical Coordinating Center for the Acute to Chronic Pain Signatures Program: Administrative Supplement

Project Summary / Abstract This application is a supplement to the parent grant entitled “Acute to Chronic Pain Signatures Program” (A2CPS) (U24 NS112873) for postdoctoral training of Dr. Giovanni Berardi. Giovanni will actively participate in all aspects of this multi-site cohort study including recruitment and retention, data collection and management, clinical site training and quality assurance, data analysis, and research dissemination. He has established training goals that are in line with the A2CPS parent grant which will provide invaluable training that will promote career development towards an early career investigator in clinical pain research. The established training aims will be focused towards developing skills necessary to conduct and coordinate multi-site cohort studies, obtaining new knowledge and skills revolving around generation of an “omics” datasets, advancing understanding in application of statistical methods to analyze large cohort datasets, and further development of research dissemination and grant writing. The addition of Dr. Berardi to the A2CPS program will facilitate completion of the parent grant aims and prepare Giovanni with attributes and skills necessary for a career in human subjects clinical pain research.

Public health relevance
Project Narrative / Public Health Relevance Statement The Acute to Chronic Pain Signatures (A2CPS) Program aims to identify biomarkers and their collective biosignatures (a combination of several individual biomarkers) that predict susceptibility or resilience to the development of chronic pain after an acute pain event through the development of a large consortium. The supplemental research and training aims will facilitate completion of the A2CPS program aims and expand Dr. Giovanni Berardi’s clinical pain research experience by gaining access to the tools and skills needed to prepare him for a career in clinical pain research. Completion of the A2CPS aims will lead to more effective and safter treatment approaches for the management of acute and chronic pain and advanced training of Dr. Berardi will add to the pool of qualified clinician-scientists investigating ways to improve the management of pain and disability.